ACTG 359--ACTIVITY OF SOFT GELATIN CAPSULE OF SAQUINAVIR IN COMBINATION

Evaluate and compare the safety and efficacy of the combination regimens of FLV/SQV/RTO or DLV/SQV/NFV and/or adefovir as salvage therapy for patients who are failing an IDV containing regimen.